STUDY TO DETERMINE ETIOLOGY OF WEIGHT CHANGE DURING ADJUVANT CHEMOTHERAPY

The purpose of this protocol is to determine the mechanism of weight gain during adjuvant chemotherapy in patients with metastatic breast cancer. Twenty-four premenopausal, non-obese women with invasive localized breast cancer receiving adjuvant chemotherapy will be studied pre- and following six cycles of therapy. Studies include determination of resting metabolic rate following on overnight fast in 60-minute recumbent test using indirect calorimetry. Serum samples will be drawn for a variety of blood, tests including estrogen and thyroid levels.